Morphogenesis: Biophysics and Genetics of Dorsal Closure

We request an NIGMS Administrative Supplement for Equipment (NOT-GM-24-021/PA-20-
272) for R35GM127059, our MIRA entitled “Morphogenesis: Biophysics and Genetics of Dorsal
Closure”. This equipment supplement will provide funds to replace selected, outdated
components of the 22 year old Zeiss AxioImager.M2m UV surgical confocaling microscope
system that is the mainstay of our biophysical investigation of embryo development and
contributes to time-lapsed analysis of dorsal closure mutations discovered through forward
genetic screens.
The new components that we seek to acquire using funds from our parent MIRA, from Duke
Institutional resources and from this requested supplement are as follows.
· A state of the art, confocaling head that can capture a wider field of view and with higher
resolution than our current system, which, because of old technology does not
adequately record images at full resolution (to be funded by this requested Supplement).
· An ORCA-Quest 2 low noise camera that has a large (4096 x 2304 pixel) qCMOS
imaging sensor, allows high frequency imaging and has increased resolution due to small
pixel size (to be funded by our parent MIRA).
· Two new, high NA objectives for biophysical surgical experiments and time-lapsed
analysis of development that are optimized for thicker biological specimen (e.g. embryos,
to be funded by Duke Institutional resources).
· A TriggerScope digital control box that interfaces the lasers and the acquisition software
to allow for high-speed triggering of the lasers and synchronization of the lasers with the
camera exposures (to be funded by our Parent MIRA).
· A Windows 11 based computer to control the system hardware, run the image acquisition
software, handle large file sizes and enable compliance with institutional security
requirements (to be funded by our Parent MIRA).
These components will modernize and expand our current imaging capabilities that are
currently, “throwing data” away. The upgraded system will provide increased resolution and
field of view and in combination with our existing computer steered laser UV microbeam for
laser microsurgery, will offer new insight in the mechanisms of cell sheet morphogenesis.

Public health relevance
Morphogenesis, the biological process that causes cells or tissues to attain their characteristic shape, is highly conserved throughout phylogeny, is fundamental to development and wound healing and can best be investigated through precise, high-resolution documentation in both time and space. We use powerful genetic and biophysical approaches to investigate cell sheet morphogenesis in the simple system, Drosophila melanogaster and request here upgrades to our > 20 year old microscope instrumentation that is out of date and badly underperforming. Our studies are designed to identify new genes that regulate and drive cell sheet movements and investigate the molecular basis for how these genes c0ntribute to morphogenesis – we provide important insights into the basic biological mechanisms that go awry in human pathologies such as cardia bifida, spina bifida, cleft palate and wound-induced, epithelial lesions.